Understanding and restoring speech production using an intracortical brain-computer interface

PROJECT SUMMARY / ABSTRACT
The goal of this proposal is to improve our fundamental understanding of speech production, and to translate this
knowledge into medical devices called intracortical brain-computer interfaces (iBCIs) that will enable people who have
lost the ability to speak to fluently communicate via a computer just by trying to speak. The study will enroll
participants who have lost or are actively losing their ability to as part of the ongoing BrainGate2 clinical trial (a multi-
site trial investigating the feasibility and safety of iBCIs in people with paralysis.) We will place four chronic 64-
channel silicon microelectrode arrays in speech areas of cortex and use simultaneously recorded speech (or attempted
speech) data and action potential-resolution neural data to characterize and decode in real time the link between neural
activity and speech production. A key advance of this approach is our ability to record simultaneously from hundreds
of individual neurons. This will provide a much more detailed view of the underlying neural computations at their
fundamental resolution – spikes – and much higher signal-to-noise ratio signals for decoding attempted speech. The
project is divided into two research areas. First, we seek to understand how networks of neurons in two closely
interacting cortical areas – ventral (speech motor) precentral gyrus (PCG) and superior temporal gyrus (STG) – generate
speech. These areas have not previously been recorded from at scale with single neuron resolution and characterizing
their dynamics will be critical for designing an effective speech iBCI. We will examine “what” parameters of speech
neurons in these two areas encode, and “when” during the preparation and production of speech different neural
computations occur. We will apply cutting-edge dynamical systems and “neural population doctrine” analysis
approaches to disentangle various components of neural activity (e.g., motoric, sensory feedback, error-processing) that
are distributed across neurons. Second, we will apply state-of-the art artificial intelligence (AI) and control theory-
inspired iBCI methods to translate the neural activity that accompanies the person’s attempt to speak into words that
appear on a computer (“Brain-to-Words”) and directly into sound (“Brain-to-Voice”). Brain-to-Words, in which speech
units such as phonemes are decoded from a slightly delayed window of neural activity, is more constrained because
the final output is whole words (which could then be spoken by the computer), without the full richness of the person’s
voice. However, it allows for powerful AI techniques to be applied to automatically correct for errors based on the
known statistics and rules of language. Brain-to-Voice can potentially restore the full expressive range of speech but
requires higher accuracy for intelligible real-time voice synthesis. However, we hypothesize that control theory-based
iBCI design and the brain’s immense ability to learn motor tasks will lead to high performance. The two project goals
work in concert: achieving the most detailed understanding to date of how neural ensembles produce speech will equip
us with the insights needed to develop a medical device that allows people to speak again with speed and accuracy
approaching that of able-bodied performance.

Public health relevance
PROJECT NARRATIVE People who lose the ability to speak due to neurological conditions including ALS or stroke have an urgent and unmet need for therapies that would restore their ability to speak. This proposal is developing a new way to help such patients using an implanted electronic medical device called a ‘brain-computer interface’ which measures the person’s brain activity with very high precision as they try to talk, and then outputs their intended words. Bypassing the injured parts of the nervous system this way requires learning to decipher how individual brain cells in the motor cortex and superior temporal gyrus – two areas of the brain involved in speaking – work together as a network to produce speech.